Targeting innate immune pathways in breast cancers with chromosomal instability

PROJECT SUMMARY/ABSTRACT
While considerable progress has been made in treating primary breast cancers, metastatic breast cancers re-
main a challenge. Metastatic breast cancer cells typically have chromosomal instability (CIN) that involves
chromosome-level alterations leading to genomic copy number abnormalities. A major challenge in targeting
breast cancers driven by CIN is the lack of known targetable alterations. We recently found that CIN pro-
motes chronic inflammatory signaling in cancer cells. As chromosomes missegregate, they often become en-
capsulated in micronuclei. Subsequent micronuclear rupture exposes genomic double-stranded DNA to the
cytosol. Cytosolic DNA activates anti-viral innate immune pathways, chief among which is cGAS-STING signal-
ing. Under normal circumstances, cGAS-STING activation promotes type I interferon and facilitates cell-
mediated immunity. Engagement of STING in normal epithelial cells induces senescence and cell death. We
have shown that cancer cells, however, are intrinsically resistant to cGAS-STING activation by virtue of their
chronic exposure to cytosolic DNA. Instead, they upregulate alternative pathways downstream of STING, such
as NF-κB signaling. The extent to which cancer cells depend on chronic inflammatory signaling is poorly un-
derstood. More importantly, how they subvert innate immune signaling to avoid immune surveillance remains
unknown. Our ongoing work reveals that cGAS-STING signaling is sequestered in cancer cells away from the
host. Furthermore, human breast tumors upregulate ENPP1, a negative regulator of cGAS-STING signaling.
ENPP1 enables immune evasion by degrading cGAMP, the second messenger produced by cGAS, only in the
extracellular space. As such ENPP1 prevents host STING activation in response to tumor-to-host cGAMP
transfer. Strikingly, pharmacologic inhibition of STING suppresses metastasis in syngeneic models of melano-
ma, breast, and colon cancers. We postulate this is because its inhibition in tumor cells outweighs its protective
role in the host. Building on this work, we will expand our pre-clinical testing of STING inhibition in breast can-
cer probing its efficacy in delaying metastasis and therapeutic resistance (Aim 1). We will then examine
whether cGAMP contributes toward the formation of an immune suppressive microenvironment through meta-
bolic breakdown in the extracellular space (Aim 2). Finally, we will develop cGAS-STING-based biomarkers in
prospectively collected tumor specimens. We will test whether the status of cGAS-STING signaling and
ENPP1 levels can predict response to neoadjuvant chemotherapy and atezolizumab, an immunotherapeutic
recently approved for the treatment of metastatic breast cancer (Aim 3). Our work addresses a clinically unmet
need by targeting a subset of breast cancers with CIN and for which there are limited therapeutic options. If
successful it will provide pre-clinical rationale for first-in-human testing of STING inhibitors for the treatment of
cancer metastasis as well as the development of novel CIN-related biomarkers to predict therapeutic response.

Public health relevance
PROJECT NARRATIVE Chromosomal instability (CIN) is a hallmark of aggressive breast cancer, yet how it contributes to the ability of cancer cells to resist therapy and spread to distant organs remains poorly understood. Our research identified that CIN promotes aggressive cancer behavior by sustaining chronic inflammation. Here, we will exploit this finding to test whether a tool compound that inhibits inflammation can suppress breast cancer metastasis and to develop novel biomarkers predictive of response to chemotherapies and immunotherapies already approved for the treatment of breast cancer.